Understanding Asthma Endotypes

PROGRAM SUMMARY
This proposal seeks to renew a successful UCSF Asthma and Allergic Diseases Cooperative Research Center
dedicated to identifying molecular phenotypes (endotypes) of asthma and understanding how these endotypes
contribute to disease pathophysiology. The proposal builds on our track record of using cell and molecular
biology tools, animal models, and human studies focused on the airway epithelium to dissect asthma
mechanisms, relate mechanisms to disease phenotypes, predict responses to existing therapies, and identify
new therapeutic targets. Work from our Center demonstrated the central importance of direct effects of the type
2 cytokine IL-13 on airway epithelial cells, identified the type 2 asthma endotype as the dominant feature in a
large asthma subgroup, established the ability of asthma endotyping to predict therapeutic responses, and
showed how IL-13-induced changes in secretory cells cause mucus plugging in fatal asthma. Recent studies
from our group and other laboratories implicate other pathways, notably the interferon (IFN) and ER stress
pathways, in some individuals with asthma. Despite the considerable progress made by our Center and many
others, there is still an urgent need for a more complete understanding of asthma disease mechanisms and more
effective therapies for the many individuals with type 2-high or type 2-low asthma who do not respond well to
current treatments. This proposal includes two projects that are highly interrelated and share a focus on the
epithelium as both a key participant in asthma pathogenesis and a useful sensor for asthma endotyping. Project
1 will determine mechanisms and consequences of heightened epithelial sensitivity to IL-13, examine the basis
of IL-13-induced changes in physical properties of mucus that cause airway obstruction, and dissect the
contributions of epithelial ER stress in both type 2- and IFN-high asthma. Project 2 will determine the clinical
significance of interferon-driven inflammation and airway epithelial ER stress in asthma, establish whether
interferon-driven inflammation and airway epithelial ER stress are resistant to and predict poor response to
existing asthma therapies, and determine whether specific inhibition of airway epithelial ER stress with a novel
therapeutic, KIRA8, improves AHR, inflammation and mucus production in allergic asthma models. A Clinical
Subject and Biospecimen Core will recruit and carefully characterize participants with asthma and healthy
controls and provide biospecimens that will be used extensively in both projects. An Administrative Core will
coordinate Center activities. Through the proposed studies we expect to gain new insights into the mechanistic
bases of asthma endotypes and better understand how to target novel pathways important in specific endotypes.

Public health relevance
PROGRAM NARRATIVE Our Center is focused on understanding how the epithelial cells that line the airways are involved in causing different forms of asthma. Our studies will uncover new knowledge about mechanisms of asthma and help to pave the way for new treatments for this common disease.